Activation of protein kinases by proline hydroxylation

Project summary
Eukaryotic protein kinases regulate important cellular processes through their ability to phosphorylate
themselves and substrate proteins. One of the phosphorylation events common to most protein kinases is the
phosphorylation that occurs at the activation loop. This phosphorylation event often occur via auto-
phosphorylation although how an inactive kinase achieves the phospho-transfer reaction on its own activation
loop site is still unclear [2]. We recently reported that activation of dual specificity tyrosine-phosphorylation-
regulated kinases 1A and 1B (DYRK1A and DYRK1B) requires prolyl-hydroxylation by the oxygen sensing
prolyl hydroxylase PHD1. DYRK1 activation by prolyl-hydroxylation instigates a sequence of events whereby
phosphorylation of ID2 by DYRK1 releases ID2 mediated constraints on VHL ubiquitin ligase tumor
suppressor complex, thus regulating the degradation of HIF proteins in brain tumors and cancer stem cells.
Our most recent work identified prolyl hydroxylation by PHD1 as the general mechanism required in trans to
prime protein kinases of the CMGC family for autophosphorylation and activation. Beside DYRK1, CMGC
kinases includes Cyclin dependent kinases (C), Mitogen activated protein kinases (M), Glycogen synthase
kinases (G) and CDC-like kinases (C). In this proposal we will follow the long-standing interest of the lab on
the molecular pathways that favor neural cell self-renewal during brain development and are aberrantly
recruited during gliomagenesis and investigate the mode of regulation of glycogen synthase kinase 3 (GSK3),
a central hub in the control of brain functions and oncogenesis. GSK3 shares with other members of the
CMGC kinase family the highly conserved CMGC insert domain. We found that this domain harbors a L/xGxP
motif and the highly conserved proline residue, Pro-276, which is targeted by hydroxylation by the proline
hydroxylase enzyme PHD1 and is necessary for kinase activation.
These observations led us to propose a combination of mechanistic and genetic studies to define the
dynamics of GSK3a/b kinase maturation induced by PHD1 and the interaction with other signaling
mechanisms that regulate GSK3 kinase activity. The significance of proline hydroxylation for gliomagenesis
will be investigated in knock-in mouse models of Pro to Ala mutation of GSK3a/b (Pro-339 and Pro-276,
respectively). Mouse tumors will be analyzed using proteomics and phosphoproteomics to reconstruct the
activity of wild type and mutant GSK3 kinases. Given the uncertain role of GSK3 kinases in cancer and
glioblastoma (promoter or suppressor), findings will lead to a better understanding of the potential
benefit/harm of GSK3 inhibitors that are currently proposed for the treatment of glioblastoma.

Public health relevance
Project narrative Eukaryotic protein kinases regulate important cellular processes through their ability to phosphorylate themselves and substrate proteins and alteration of the mechanisms that control kinase activation leads to pathological conditions including cancer. Here we will investigate a novel mechanism of kinase activation through hydroxylation of proline residues by proline hydroxylase enzymes. We will determine the functional impact of the signaling pathways converging on proline hydroxylases, the cancer phenotypes elicited in the mouse brain by dysregulation of this novel pathway of kinase activation and the consequences on the global proteome and phosphoproteome.